Validation of a novel and more accurate endpoint for GVHD clinical trials

ABSTRACT
Acute graft vs. host disease (GVHD), attacks the skin, liver, and/or GI tract, is treated with high doses of
steroids, and is the primary cause of non-relapse mortality (NRM) in patients undergoing allogeneic
hematopoietic cell transplantation. The overall response rate (ORR) to treatment that combines complete
(CR) and partial response (PR) at day 28 (D28) was accepted by the FDA as evidence of therapeutic
benefit in a clinical trial based on both accuracy and timeliness: it was the earliest time point that stratified
patients for NRM (and survival) among several evaluated. Disadvantages to D28 ORR as the primary
endpoint for clinical trials include: (1) lack of inclusion of severity at onset in calculating response; (2) all
target organ responses are weighted equally despite the fact that NRM is driven by GI GVHD; (3) symptom
severity often reflects the presence of confounding factors; and (4) CR and PR response groups have the
same long-term outcomes and thus cannot support different approaches to GVHD of differing severity.
This application proposes to validate a new model that overcomes these disadvantages. The Mount Sinai
Acute GVHD International Consortium (MAGIC) algorithm probability (MAP) uses serum biomarkers to
calculate a risk score that predicts long-term outcomes after treatment. Our preliminary “real world” data
show that (1) a D14 MAGIC clinical model that accounts for symptom severity both at onset and D14 is as
accurate a surrogate for long-term outcome as D28 ORR; and (2) a new MAGIC integrated response that
adds the D14 MAP to the new D14 MAGIC clinical response more accurately predicts long-term outcomes
than D28 ORR. The D14 MAGIC integrated response also creates three response groups with distinctly
different outcomes. These findings require confirmation in patients who were treated in the context of
clinical trials. We propose to use existing clinical and laboratory data from five multicenter GVHD treatment
trials (n=682 patients) to test the hypothesis that novel D14 clinical trial endpoints are accurate surrogates
for one-year NRM. In Specific Aim (SA) 1, we will validate the D14 MAGIC clinical response an accurate
surrogate for 1 year NRM if both sensitivity and specificity are non-inferior to D28 ORR. Other performance
measures such as balanced accuracy (average of sensitivity and specificity), PPV, NPV, and AUC for NRM
will provide a comprehensive comparison between the two clinical endpoints. In SA2, we will validate the
D14 MAGIC integrated response as the best surrogate for 1y NRM if its balanced accuracy is significantly
better than D28 ORR. We will also analyze the performance of different definitions of treatment response
when there are three, rather than two, distinct response categories. If successfully validated these novel
endpoints will be the first advance in GVHD clinical trial design in 15 years and provide the ability to tailor
trial endpoints to different treatment goals as conceived when CR and PR groups were defined.

Public health relevance
NARRATIVE Acute graft-vs-host disease (GVHD), the major complication after allogeneic hematopoietic cell transplant, requires more efficacious and safer treatments. A novel trial endpoint that is a more accurate surrogate for long-term outcomes and can be tailored to different treatment goals will advance clinical research designs for GVHD. This application will validate a new trial endpoint with existing clinical and laboratory data from five GVHD treatment trials in compliance with the requirements of PAR-23-036.